NF-kappaB and Mitochondrial Signals as Positive and Negative Regulators of Inflammation

ABSTRACT
In the past three years, we made great progress in understanding the role of mitochondrial (mt) DNA metabolism
in NLRP3 inflammasome activation. Importantly, we found that NLRP3 itself is activated on binding of oxidized
(Ox) mtDNA, whose generation depends on new mtDNA synthesis which is stimulated on TLR engagement.
TLR signaling results in induction of CMPK2, which catalyzes the rate limiting step in the biosynthesis of dCTP,
a precursor for mtDNA synthesis. We recently discovered that Ox-mtDNA needs to be cleaved by the
endonuclease Fen1 and transported/leaked to the cytoplasm, where NLRP3 is located, via the mitochondrial
inner membrane (MIM) MPTP pore and the mitochondrial outer membrane (MOM) VDAC channel. Macrophage
exposure to different NLRP3 activators results in rapid Ca2+ influx into mitochondria, as well as perturbations to
the electron transfer chain that result in mtROS production. Whereas Ca2+ influx into mitochondria leads to pore
and channel opening, mROS lead to oxidation of newly synthesized mtDNA before it is cleaved by Fen1 to 600
bp fragments that leak into the cytoplasm. Another important player in mtDNA metabolism is OGG1, a baseexcision repair enzyme that removes oxidized deoxyguanosine from mtDNA, whose insufficiency greatly
increases Alzheimer’s disease (AD) risk. We found that OGG1 ablation in macrophages enhances NLRP3
inflammasome activation, whereas mitochondrially targeted OGG1 inhibits NLRP3 inflammasome activation. We
therefore we plan to study the involvement of mtDNA metabolism in AD pathogenesis, using the accelerated
5xFAD model crossed with ApoE4 knockin mutant mice. These mice will be analyzed over the course of disease
development and progression for CMPK2, NLRP3, ASC, caspase-1, OGG1 and Fen1 expression and presence
of Ox-mtDNA and mature IL-1β in their circulation, cerebrospinal fluid, and brain tissue homogenates. Microglia
(MG) from these mice will be isolated at different time points and analyzed for presence of ASC specs, indicative
of NLRP3 inflammasome assembly, presence of cytosolic mtDNA and signs of MPTP opening and VDAC
oligomerization. We will determine whether crossing of 5xFAD/ApoE4 mice with mtOgg1Tg mice results in
reduced abundance of cytoplasmic mtDNA, Ox-mtDNA and IL-1β and whether this parallels the amelioration of
neurodegeneration and cognitive loss. Conversely, we will delete OGG1 in MG of 5xFAD/ApoE4 mice to
determine whether this results in accelerated development of neurodegeneration. We will also cross
5xFAD/ApoE4 and Cmpk2ΔMG mice, in which the Cmpk2 gene was ablated with MG-specific Cre and determine
whether this also results in disease amelioration. According to the results of the above experiments,
5xFAD/ApoE4 mice will be treated with newly developed CMPK2 and Fen1 inhibitors and will be evaluated for
attenuation of neurodegeneration and cognitive loss. Human AD tissue will also be examined for CMPK2 and
Fen1 expression as well as presence of ASC specs and Ox-mtDNA. These studies will provide us with a
comprehensive view of mtDNA metabolism in AD and will determine whether some of the key steps in the NLRP3
activation pathway, we had identified, are suitable for therapeutic intervention. In addition to AD, we will assess
the contribution of mtDNA metabolism to osteoarthritis (OA), a chronic degenerative disease that unlike
rheumatoid arthritis does not respond to anti-TNF drugs. It has been suggested that NLRP3 activation by
hydroxyapatite microcrystals is the trigger for OA. We are currently working on the establishment of a robust OA
model and when it is ready, we will test the effect of CMPK2 and Fen1 inhibition, as well as mtOGG1 expression,
on disease progression and severity. We will also determine whether mouse and human OA specimens show
the same perturbations in mtDNA metabolism discussed above. As IL-1β neutralizing antibody was found to
reduce the incidence of lung adenocarcinoma (LUAC) in smokers, we will also examine whether NLRP3
inflammasome activation in alveolar macrophages plays a key role in LUAC development and if so will test the
ability of CMPK2 and Fen1 inhibitors to attenuate disease progression. We will also investigate whether
macrophage- or MG-specific activation of NRF2 can attenuate neurodegeneration, cognitive loss, OA and LUAC
pathogenesis using mouse models of the above diseases. These studies are based on our preliminary studies
which show that macrophage-specific NRF2 activation alters macrophage polarization and reduces the
production of various inflammatory cytokines. We will further investigate the mechanism underlying this outcome
and determine its association with altered mitochondrial metabolism.

Public health relevance
RELEVANCE (See instructions): We will continue to study the role of mitochondrial DNA metabolism in NLRP3 inflammasome activation and the effect of NRF2 on macrophage polarization. We will examine whether the pathogenesis of osteoarthritis (OA) and Alzheimer’s disease (AD) in mice is accompanied by oxidized mitochondrial DNA generation, its cleavage and export to the cytosol. We will also test the ability of CMPK2 and Fen1 inhibitors to attenuate NLRP3 inflammasome activation in OA, AD and other disease models.